Neuron-specific modulation of gene expression using systemically administered bispecific antibody-ASO conjugates

The ability to selectively modulate the expression of one or more neuronal genes is critical for defining pathways
that govern normal brain physiology and diverse disease phenotypes. Anti-sense oligonucleotides (ASOs) are
attractive agents for manipulating neuronal gene expression, especially given their clear advantages relative to
gene therapy, including that ASO therapy is reversible, nonimmunogenic, and independent of gene size.
However, progress has been limited by the need for invasive routes of administration [e.g.,
intracerebroventricular (ICV) injection], limited cellular uptake, and lack of cell-type specificity. A technology
capable of delivering ASOs across the blood-brain barrier (BBB) and specifically into neurons following
intravenous (IV) administration – resulting in modulation of neuronal gene expression – would be incredibly
useful. Therefore, we have developed a bispecific antibody (bAb) shuttle that targets CD98hc, the heavy chain
of the large neutral amino acid transporter (LAT1), and mediates delivery of IgGs across the BBB. We observe
superior brain retention of IgGs shuttled via CD98hc, as compared to shuttling via transferrin receptor (TfR-1).
Moreover, we do not observe cellular uptake of CD98hc bAbs in the brain parenchyma unless targeted to specific
cell types, which is unique relative to TfR-1 bAbs. We have also developed a first-generation CD98hc bAb that
targets glycoprotein M6A, which is selectively internalized into neurons in the mouse brain. Finally, we have
optimized the conjugation of azide-functionalized ASOs to our bAbs. Therefore, the first objective is to test the
efficacy of our first-generation, neuron-specific bAb – when conjugated to a Scn1a ASO that increases the
expression of NaV1.1 – for increasing the threshold of temperature-sensitive seizures and restoring intrinsic
excitability of parvalbumin-expressing inhibitory neurons in a mouse model of Dravet syndrome (Scn1a+/-). The
second objective is a method development study aimed at developing second-generation bAbs that target
different cell-surface proteins enriched on neurons and evaluating their specificity for reducing Malat1 gene
expression as bAb-ASOs using single-cell RNA-seq and single-molecule fluorescent in situ hybridization.
Therefore, in Aim 1, we propose to evaluate the efficacy of first-generation bAb-ASOs for increasing neuronal
expression of NaV1.1 and improving associated phenotypes in Scn1a+/- mice. We will generate M6A/CD98hc
bAbs conjugated to our validated NaV1.1 ASO and evaluate their impact on temperature-sensitive seizures and
intrinsic excitability of parvalbumin-expressing inhibitory neurons in Scn1a+/- mice. Next, in independent Aim 2,
we will evaluate gene silencing of second-generation bAb-ASOs that target different cell-surface proteins
enriched on neurons (e.g., synaptophysin, GRIA1, CHRM3). We propose to use a validated ASO against a non-
coding gene (Malat1) given that this gene is expressed in all brain cell types and its knockout does not produce
a phenotype. A key expected outcome is the characterization of bAb-ASOs that selectively modulate gene
expression in neuronal cells after IV administration, which has a staggering number of potential applications.

Public health relevance
The goal of this proposal is to improve the delivery of agents that increase or decrease gene expression – which are named anti-sense oligonucleotides – in a selective and non-invasive manner to neurons in the brain. This research will involve conjugating anti-sense oligonucleotides to binding proteins (antibodies) that penetrate the blood-brain barrier, target proteins on neurons, release their conjugated agents after cellular internalization, and modulate gene expression. Successful completion of this research would enable a broad range of fundamental neuroscience and therapeutic applications, including treating diseases such as Dravet syndrome and other brain disorders.